Identifying the Role of the IL-6/STAT3 Signaling Pathway in Higher-risk Myelodysplastic Syndrome

Myelodysplastic syndromes (MDS) are myeloid malignancies most commonly diagnosed at an advanced age.
They are considered a spectrum of malignancies that can range from low to high grade and they are classified
based on an international prognostic system. This prognostic system separates them into a range from very low
risk with survival rates of several years to very high risk with survival rates of less than a year. Therapeutic
interventions have focused on targeting higher risk MDS (from intermediate to very high risk), as the benefit of
disease-modifying therapies far outweighs the risk of adverse effects from such therapies. Research aimed at
developing targets for this disease has described the presence of a subpopulation of leukemia stem cells, which
give rise to the disease and are therefore a critical target to eradicate this malignancy. Prior studies have defined
metabolic properties of leukemia stem cells, including their reliance in mitochondrial function and oxidative
phosphorylation; therefore, targeting oxidative phosphorylation is a potential avenue for eliminating this
subpopulation within MDS cells. There are currently very limited therapies aimed at targeting leukemia stem
cells, and this is an unmet need in this field. The candidate’s long-term goal will be to develop new therapeutic
strategies aimed at targeting this subpopulation. The hypothesis of this study is that signal transducer and
activator of transcription 3 (STAT3) regulates mitochondrial function of leukemia stem cells via regulation of
several nuclear-encoded genes that are crucial for proper function of the mitochondria, while also translocating
to the mitochondria and modulating the function of the electron transport chain. Aim 1 will elucidate whether the
IL-6/STAT3 signaling pathway regulates nuclear genes involved in survival of intermediate to very high risk MDS
stem cells. Aim 2 will determine whether IL-6/STAT3 signaling regulates the mitochondrial function of higher-risk
MDS stem cells. This will be studied by investigating the importance of STAT3 interactions with other proteins in
the mitochondria. To determine if either of these roles is essential for survival of leukemia stem cells, Aim 3 will
investigate whether targeting IL-6 or STAT3 decreases the engraftment potential of human primary MDS patient
samples in immune-deficient mice. Based on these findings, targeting STAT3 and IL-6 will be tested in in vivo
models.

Public health relevance
The goal of this proposal is to develop an improved therapeutic strategy for myelodysplastic syndromes (MDS). MDS is a heterogeneous group of malignancies that are diagnosed in about 15,000 people in the U.S. per year. Lower risk patients have a good prognosis and are treated with supportive care, while outcomes for higher risk patients are poor and these patients carry a risk of progression to acute myeloid leukemia (AML). Treatment options for this disease are limited, and studies aimed at finding new therapeutic strategies are needed. MDS has a distinct population of stem cells that can give rise to the disease, and targeting this population could represent a powerful tool in the treatment of MDS with the potential to eradicate the disease. Leukemia stem cells (LSCs) rely on mitochondrial function and oxidative phosphorylation for survival, making this the Achilles’ heel of LSCs and a potential target in MDS. This project will evaluate how STAT3 regulates the mitochondrial function of leukemia stem cells in higher-risk MDS.